Increasing synaptic PSD-95, a neuroprotection approach against Alzheimer's disease

Project Summary/Abstract
The first change in the brains of Alzheimer’s patients and the best biomarker of the disease is synaptic loss.
Several studies have shown that PSD-95 (a major scaffolding protein at the synapse) is significantly depleted
in brain tissue of Alzheimer’s patients as well as in neurons exposed to amyloid beta (Aβ, a peptide thought
to cause Alzheimer’s disease (AD)). Our data indicate that elevated PSD-95 blocks Aβ-induced synaptic
depression. Surprisingly, this effect appears independent of synaptic potentiation, but to interference by PSD-
95 of NMDA receptor signaling. Moreover, we observed that big dendritic spines, containing a lot of PSD-95,
were unaffected by Aβ and that smaller spines, with lower amounts of PSD-95 were more vulnerable;
suggesting that endogenous PSD-95 is also protective. These findings indicate that increased synaptic PSD-
95 protects synapses from Aβ. The amount of synaptic PSD-95 is controlled by a process called
‘palmitoylation’ which mediate the insertion of PSD-95 in post-synaptic membranes. The specific enzyme
responsible for PSD-95 depalmitoylation, which removes PSD-95 from synapses, was recently identified. The
key focus of this proposal is thus to test the potential of a novel drug target, PSD-95 depalmitoylating
enzyme, as a new therapeutic avenue against Alzheimer’s. Our preliminary in vitro and in vivo results, using
a commercially available inhibitor of that enzyme (Palmostatin B), are very promising. In vitro experiments
showed that this drug could rescue Aβ-induced synaptic depression and Aβ-mediated effects on dendritic
spines. We propose to study PSD-95 palmitoylation in brain regions differently affected in the disease in AD
model mice (APP/PS1) and postmortem human brain samples. These experiments could explain why certain
brain regions (and individuals) are more vulnerable to AD. In APP/PS1 mice, PSD-95 palmitoylation in the
hippocampus was drastically lower than in WT littermates while total PSD-95 levels were barely affected.
This suggests that loss of PSD-95 palmitoylation would happen before reductions in PSD-95. Importantly,
Palmostatin B injections in the intraperitoneal cavity rescued that effect in a dose dependent manner, which
indicates that this drug can access brain synapses in vivo. In this project, we will investigate the functional
consequences of that rescue and test if deficits observed in these APP/PS1 mice can be ameliorated by
increasing synaptic PSD-95. We expect that inhibiting PSD-95 depalmitoylation will improve performance in
behavioral tests involving memory and rescue synaptic physiology impairments in these AD model mice.
Overall, this innovative project will characterize PSD-95 trafficking in different brain regions and test if
pharmacological blockade of PSD-95 depalmitoylating enzyme can rescue deficits in APP/PS1 model mice.
Finally, increasing synaptic PSD-95 should make vulnerable synapses stronger, which would be beneficial for
both treating and preventing AD.

Public health relevance
Project Narrative This project will characterize key cellular and molecular events that participate in the development of Alzheimer’s disease and identify therapeutic pathways to reverse these pathological events. We discovered that synapses containing elevated amounts of PSD-95 are protected against the detrimental effects of amyloid- beta, a peptide thought to cause Alzheimer’s disease. We will study PSD-95 in several brain regions as it might explain cell vulnerability and develop a pharmacological approach to increase synaptic PSD-95, which has the potential to open a new therapeutic avenue against Alzheimer’s.